P30 Administrative Supplement for Early-Onset Cancer Research: Repurposing orphan drugs for early-onset endometrial cancer

PROJECT SUMMARY/ABSTRACT
Endometrial cancer (EC) is the 4th most common cancer in women but has been understudied due to
curative hysterectomy being available for patients with early-stage disease. As the incidence for EC rises year
over year, the rates of early-onset EC (patients under 50 years of age) have risen more rapidly. Recent studies,
including our own, have identified KMT2D as a gene with high mutation rates among early-onset tumors.
KMT2D is a histone methyltransferase which regulates enhancer function. Our preliminary findings show that
KMT2D-deficiency upregulates the Rb/E2F pathway through histone methylation mis-localized to the promoter.
We developed both CRISPR-mediated cell line knockouts of KMT2D and a genetically engineered mouse
model of KMT2D-driven EC. In both models, we observe an upregulation of the CDK1 protein. CDK1 has been
shown to be sufficient for cell cycle progression in the absence of CDK2, 4 and 6 expression, and CDK can
phosphorylate Rb as a non-canonical activity. Currently, there are ongoing clinical trials testing CDK4/6
inhibitors Abemaciclib and Palbociclib for use in endometrial cancer. Here, we propose instead that CDK1
inhibitors, including FDA-approved orphan drugs Alvocidib and Dinaciclib, may be a viable solution for the
treatment of KMT2D-deficient early-onset endometrial cancer. Our hypothesis is that KMT2D mutations exist
as an alternative pathway for EC which disproportionately affects patients with early-onset disease,
contributing to disease progression through upregulation of CDK1 and are susceptible to therapeutic inhibition
of CDK1. Our Specific Aims are (1) to characterize the role for CDK1 in driving KMT2D-deficient tumors and (2)
to evaluate the efficacy of orphan drugs Alvocidib and Dinaciclib in KMT2D-loss-driven endometrial tumors.
Using mouse models, cell models and patient tumors, we will characterize the impact of KMT2D loss on the
CDK1 expression and evaluate the therapeutic efficacy of Alvocidib and Dinaciclib in this context. In Aim 1, we
will use a panel of high-grade, early-onset EC tumors to measure the expression of CDK1 and correlate with
KMT2D mutation. Using RNA-seq data from these tumors, we will evaluate the role for KMT2D in regulation of
E2F/Rb among early-onset tumors, and evaluate how this differs from late-onset tumors. We will examine the
role for CDK1 protein expression in relation to E2F/Rb signaling amongst this subgroup of tumors. In Aim 2, we
will utilize both CRISPR knockout cell lines and our novel genetically engineered mice harboring KMT2D-loss-
driven tumors to determine the efficacy of CDK1 inhibitors Alvocidib and Dinaciclib in the context of KMT2D-
mediated EC. Our studies will define KMT2D as a biomarker for response to anti-CDK1s and provide clinical
rationale for the use of these orphan compounds in the context of early-onset EC. Our lab’s long-term goal is to
develop personalized therapies for underserved subgroups of EC patients, including those with early-onset
disease.

Public health relevance
PROJECT NARRATIVE Early-onset endometrial cancer is an ongoing public health problem, as incidence is increasing year over year and new treatments have not been developed. We have identified high mutation rates of the gene KMT2D among early-onset cases and have shown through our preliminary studies that these tumors may be sensitive to a group of “orphan drugs” which are FDA approved and safe for patients, but not often used due to limited applications. We propose here to study the potential for orphan drugs Alvocidib and Dinaciclib as treatments for KMT2D-deficient early-onset endometrial cancer, which we estimate accounts for about 4,000 new cases per year.